Molecular Mechanisms of anti-bacterial contact-dependent growth inhibition (CDI)

Bacteria have evolved complex strategies to compete and communicate with one another. One important
mechanism of inter-bacterial competition is mediated by contact-dependent growth inhibition (CDI) systems.
CDI systems are found in a wide variety of Gram-negative bacteria, including many important human
pathogens. CDI is mediated by the CdiB-CdiA family of two-partner secretion proteins. CdiB is an Omp85
outer-membrane protein that is required for the export and assembly of CdiA effector proteins onto the cell
surface. CdiA binds to receptors on susceptible bacteria and then delivers its C-terminal toxin domain (CdiA-
CT) into the target cell. CDI systems also encode CdiI immunity proteins, which bind the CdiA-CT and
neutralize toxin activity to protect CDI+ cells from auto-inhibition. Remarkably, CdiA-CT sequences are highly
variable between bacteria, as are the corresponding CdiI immunity proteins. Current analysis indicates that
CDI systems encode at least 120 distinct CDI toxin-immunity families. This application proposes a combination
of genetic, biochemical and ultrastructural analyses to gain mechanistic insights into cell-cell interactions and
CdiA-CT toxin delivery during CDI. This research will significantly increase our understanding of the ecology
and evolution of bacterial pathogens and could inform novel approaches to antimicrobial therapy.

Public health relevance
Bacteria have evolved complex strategies to compete and communicate with one another. Contact-dependent growth inhibition (CDI) is an important mechanism of inter-bacterial competition, and these systems are distributed widely amongst Gram-negative bacteria, including several important human pathogens. This application proposes a combination of genetic, biochemical and ultra-structural approaches to gain insights into the molecular mechanisms that control inter-bacterial toxin delivery during CDI. This research will significantly increase our understanding of the ecology and evolution of bacterial pathogens and could inform the development of novel antimicrobial therapies.